Pilot & Feasibility Program

Abstract:
The CF RTCC Pilot and Feasibility Program proposes overseeing and funding pilot projects. The first specific
aim is to select two P&F grants. We will utilize a process that includes: 1) an “early” (six months prior to
submission date) and widely disseminated Pilot & Feasibility Program announcement (on the UNC CF
Center/CGIBD websites, e-mail networks, and through oral disclosures at CF and CGIBD Center meetings) of
the availability of Pilot & Feasibility projects; 2) a “pre-review” of one to two page outlines of Pilot & Feasibility
Projects by the PI and Co-Directors of the CF RTCC (Boucher, Sartor, Donaldson); 3) a review (including an
NIH-type priority score) of the Pilot & Feasibility Programs by the PI, Co-Director, Internal Advisory Committee,
and at least two members of the External Advisory Committee who are experts in the area pertinent to the P&F;
and 4) a review at ten months into Yr. 1 of the progress of the Pilot & Feasibility Projects to assess the need to
fund Year 2. We have also developed a database/tracking mechanism to follow in the outlying years the success
of the P&F Program in developing the science required for successful R01 or multi-investigator grant
applications, including Program Projects. The breadth of the research areas serviced by the CF RTCC can be
seen in the synopsis of the P&F Projects that were selected for the one to two page submission format. However,
in keeping with our mission to relate airway (mucus) pathophysiology to the GI tract, both selected P&F projects
were thematically grouped. The two P&F projects selected are: 1) Discoordinate Regulation of Mucin and Fluid
Secretion in Stem Cell-Derived CF Gut Epithelia (C. Ehre, PI); 2) The Two-Gel Model Applied to Normal and CF
Gut Epithelia (V. Shenoy, PI).